Society for Basic Urologic Research 2021 Annual Meeting: Molecular Mechanisms of Urological Diseases and Treatment Resistance

This application requests support for the Society for Basic Urologic Research (SBUR) 2021 Annual Meeting
entitled, “Molecular Mechanisms of Urological Diseases and Treatment Resistance”, which will be held on
November 4-7, 2021 at the JW Marriott Orlando Grande Lakes, Orlando, FL. This conference has been held
annually since 1992 and provides a unique environment to learn about the most recent advances in basic,
translational, and preclinical urologic research, in addition to providing a dynamic forum for discussing how
these advances could be implemented for the prevention and treatment of urological diseases. Much has been
learned over the last decade regarding the molecular determinants and key pathways that regulate normal and
disease processes, and a wide variety of novel therapeutic and diagnostic strategies have emerged as a result.
Thus, this year’s meeting will focus on a few areas that are emerging as the cutting-edge advances in urology,
including: 1) Emerging Technologies and Models for Urological Research; 2) Endocrine and Genetic
regulations in Urological Biology; 3) Epigenetic Regulations of Urological Development and Diseases; 4)
Infection, Inflammation, and Immune Response in Urological Biology; 5) Biomarkers, Environmental Factors,
and Health Disparities in Urological Diseases; 6) Urological Stem cells, Lineage Plasticity, and Treatment
Resistance. The support from this application will be used to provide 24 Travel Awards and 4 Minority Scholar
Awards to disadvantaged, poorly represented, trainees and junior to mid-career investigators to defray travel
costs, with the intention of providing much-needed encouragement and promotion to a career in urologic
research and of enhancing the diversity of conference attendees. In addition to highlighting recent advances
and identifying key knowledge gaps, the primary goals of the conference are: 1) Discuss recent advances in
studying the molecular mechanisms of urologic development and diseases using contemporary technologies,
with emphasis on novel methodologies and tools, genetics, epigenetics, infection, inflammation and immune
response, environmental factors and health disparity, and stem cells and lineage plasticity; 2) Identify critical
knowledge gaps and stimulate approaches to address them; 3) Attract leading scientists from diverse fields in
malignant and benign urology; 4) Promote interactions between basic, translational and clinical research
scientists of diverse backgrounds and facilitate cross-disciplinary communication and collaboration; 5) Foster
the active participation of women, minorities, the disabled, and early career investigators by providing them
opportunities to present and discuss cutting-edge science and enhancing their integration into the field; and 6)
Disseminate and facilitate novel discoveries in urologic diseases. An attendance of at least 250 is expected,
and we will recruit a large variety of clinician, physician-scientist, and basic researcher attendees, with special
emphasis on early-career investigators and groups typically underrepresented in urologic research. Finally, a
robust plan is in place for publicizing the conference and the support, if awarded, by NCI and NIDDK.

Public health relevance
The Society for Basic Urologic Research (SBUR) 2021 Annual Meeting will create a unique opportunity to highlight the latest advances in understanding the biology and therapy of urologic diseases; identify key knowledge gaps and new research opportunities; and build collaborations to integrate basic and translational research across the growing sub-disciplinary interests in Urology. Anticipated attendance will include established basic and clinical researchers, junior investigators, PhD and medical students, postdoctoral fellows and medical residents from diverse areas of Urology. Given this breadth of diversity, this meeting will stimulate new thinking, break down barriers, and catalyze the field.